Investigation of a neuromesendodermal progenitor population in the posterior avian endoderm

PROJECT SUMMARY/ABSTRACT
Transformation of the early embryo from a seemingly disorganized ball of stem cells to the complex and
precisely patterned adult form requires stereotyped regulation cell behaviors via biophysical and biochemical
cues. Using the chick embryo, the long term goals of my research program are to understand from a highly
quantitative perspective how this is orchestrated. Approximately half of the lab focuses on mechanobiology of
embryonic development, seeking to understand the forces that shape tissues and organs in the embryo and
the cues that specify those forces. The remainder of the lab studies cell fate determination, either in the context
of early brain development or in the developing gut. The present application stems from the latter.
During embryonic development, one of the first major steps in lineage segregation is gastrulation, when a
single totipotent layer of cells separates into three germ layers, endoderm, mesoderm, and ectoderm. While
conventionally, it has long been accepted that all progenitors of each germ layer are generated only during
gastrulation, recent studies have challenged this, identifying a multipotent progenitor population that persists
after gastrulation ends in the tailbud. Within this population, known as neuromesodermal progenitors, a single
cell can give rise to progeny that contribute to both notochord (mesoderm) and neural tube (ectoderm). While
studying gut tube formation in the chick embryo, we recently identified a population of endoderm cells that line
the ventral surface of the tailbud, and appear to undergo a widespread and previously unreported epithelial-to-
mesenchymal transition (EMT). These cells invade the neighboring tailbud tissue, reaching as far as the dorsal
surface of the tailbud. Importantly, cells can be seen dispersed throughout the region where neuromesodermal
progenitors are known to reside, as well as in the neural tube and notochord. This suggests that these
endodermal cells represent an unappreciated source of neuromesodermal progenitors, which, if they retain the
ability to generate endodermal tissues as well, would be remarkable. The present application combines
classical embryology approaches such as fate mapping and grafting experiments with gene misexpression and
single-cell RNA Sequencing in an effort to make sense of the simple yet puzzling observation that endoderm
cells undergo a localized EMT and invade the tailbud at a time when gastrulation is complete. The proposal
aims to identify the tissues to which this prospective progenitor population contributes, and to construct a
detailed single-cell transcriptomic atlas of this population, from which identity, regulatory circuits, and proposed
lineage trajectories can be inferred. At the completion of the proposed work, we will have established a new in
vivo model to study endodermal EMT, and potentially identified a novel stem cell population residing in the
endoderm, with the ability to give rise to mesodermal and ectodermal cells. This stands in contrast to long-held
notions of lineage segregation during embryonic development, and therefore has the potential to be
transformative for the fields of developmental biology and stem cell reprogramming.

Public health relevance
PROJECT NARRATIVE Understanding how cell fates are specified in the embryo is a long standing goal of developmental biology. Here we explore a previously unappreciated epithelial to mesenchymal transition in the posterior endoderm, one of the three germ layers that comprise the early embryo, wherein cells invade the neighboring tailbud mesenchyme and potentially contribute to neuromesodermal fates. Understanding signals that regulate this process, the identity of these cells and their progeny, and their potential to differentiate along a remarkably wide range of lineages may have potentially far reaching implications for the study of induced pluripotency, cell reprogramming, and directed differentiation, as well as the pathogenesis of cancer, which commonly originates in endodermally derived tissues, and propagates via epithelial to mesenchymal transition.